RP-2: Discovery and Characterization of Novel Genes and DNA Repair Pathways Predisposing to Urothelial Cancer

PROJECT SUMMARY/ABSTRACT
Bladder (urothelial) cancer has a substantial inherited component, with an estimated heritable
fraction of approximately 30%. Genome-wide association studies document an estimate of
familial relative risk for urothelial cancer similar to that seen in familial bladder cancer registries
(1.37 vs 1.69). Highly penetrant cancer susceptibility genes such as those in the mismatch-
repair pathway (eg, MSH2, MSH6) account for only a small fraction of genetic susceptibility to
urothelial cancer. There are also numerous reports of multiple-case urothelial cancer kindreds
that have not yet been systematically studied using modern sequencing methodologies. Using
bait capture next-generation sequencing assays of paired somatic and germline DNA, we
showed that that 20% of urothelial cancer patients have moderate- to highly-penetrant known
predisposition genes. Approximately 70% of these genes are in DNA damage response gene
pathways, genes that predispose for a broad spectrum of non-urothelial cancers. Preliminary
data also identified a novel mechanism of bladder cancer susceptibility in a nucleotide excision
repair pathway. This project seeks to identify novel urothelial cancer susceptibility genes by
genotyping DNA from >480 kindreds demonstrating familial urothelial cancer, ~275 patients with
early (≤ age 45) and extremely early (≤ age 30) disease onset, and a selected subset of over
1000 patients in whom urothelial cancer is a component of multiple primary cancers of which
one is urothelial cancer. We will utilize next-generation sequencing assays of paired somatic
and germline DNA to identify loss of heterozygosity in bladder tumors, as well as interrogation of
germline genomes and exomes from familial and early-onset cases to discover putative bladder
cancer susceptibility genes. We will assess candidate genes that may contribute to hereditary
urothelial cancer in the above-mentioned kindred studies, genes in pathways governing DNA
repair, and genes identified in prior genome-wide association studies. For both the discovery
and validation phases, we will utilize pre-formed cohorts of 3,000 cases and 3,000 controls for
genetic and genetic epidemiologic studies at MSK, augmented by cases provided by national
and international collaborators, including a highly informative subset ascertained by NCI
investigators. To inform the discovery of putative urothelial cancer susceptibility genes, we will
pursue functional characterization of deleterious genetic mutations identified by the above-
mentioned genetic epidemiologic approaches.

Public health relevance
Project Narrative This project seeks to discover predisposition genes that can lead to the development of urothelial cancer by utilizing the latest technologies in genetic sequencing. The project will draw from unique resources at both the national and international levels, with the hope of discovering and validating novel urothelial cancer susceptibility genes.